Imaging and Radiation Oncology Core (IROC) Group

The primary objective of the Imaging and Radiation Oncology (IROC) Group is to
provide scientific and technical expertise for incorporation of appropriate, integrated
quality Assurance (QA) and image data management for both imaging and radiotherapy
(RT) in applicable trials conducted by the National Clinical Trials Network (NCTN)
Program and other NCI funded clinical trial groups (NCORP and ETCTN). The physical
IROC QA Centers are distributed in 4 main locations and are administratively organized
through the American College of Radiology (ACR). The QA Centers include IROC
Houston, IROC Ohio, IROC Rhode Island, and IROC Philadelphia. The Advanced
Technology QA Center (ATC) located at Washington University, St. Louis will provide
their expertise and consultation services to IROC as needed. IROC capitalizes on
existing infrastructure and expertise at QA centers currently providing services to the
NCI’s clinical trial programs. Work flows, processes and information systems have been
enhanced taking into account the best practices and standards in an integrated vision
across NCI’s clinical trials. The interdependencies between imaging and RT are
synergized eliminating duplication of services and optimizing efficient and effective
workflows. A major strength of IROC is the development of consistent standard
operating procedures for all imaging and RT aspects of the NCTN, NCORP and ETCTN
(NCI Groups) and to facilitate a seamless flow of imaging and RT patient case datasets
across the networks. IROC’s organizational structure allows the delivery of a broad array
of imaging and RT QA services including Site Qualification; Trial Design Support;
Credentialing; Data Management (Pre- and Post-treatment Case Review); and Case
Review. An information technology infrastructure is used that harmonizes IROC
services, data collection, assessment and management for the NCI Groups’ clinical
trials. IROC implements programs that assure consistent high quality imaging and RT
planning/delivery across the NCTN participating sites. IROC members collaborate with
the NCI, NCI Groups, and disease/modality committees within each Network Group to
provide an optimum and effective imaging and RT core service. The IROC Group will
analyze QA data obtained prospectively/retrospectively and the correlation it might have
with clinical trial outcomes to better determine and prioritize appropriate QA activities
that maximize their benefit to clinical trials.

Public health relevance
Today’s cancer trials frequently require the use of imaging and/or radiation therapy to achieve the most effective treatment. Rigorous QA of these methodologies secures consistency across participating sites by managing potential variability which would otherwise obscure true therapeutic outcomes.